PROBING LIGAND BINDING SITE OF 2 ADRENERGIC RECEPTOR W/ PHOTOAFFINITY LABELS

Ser204 and Ser207 on Transmembrane 5 (TM5) of the β2 adrenergic receptor (β2AR) are critical in interactions with catecholamines and other β2AR binding ligands. It is believed that the hydroxyls of these two amino acid residues form hydrogen bonds with β2AR agonists and antagonists. In this research project, a recombinant β2AR with Ser204 to Cys (S204C) or S207C will be constructed, expressed in sf9 cells of baculovirus expression system. The purified receptor will be radiolabeled with thiocatecholamine derivatives ([125I]-1-(1-oxy-3-hydroxy-4-thio-phenyl) -3-(N-iodo-tyramine)-2-propanol and ([125I]-1-(1-oxy-3-thio-4-hydroxy-phenyl)-3-(N-iodo-tyramine)-2-propanol which have a thio group attached to the catechol phenyl ring instead of a hydroxyl group. In addition, novel photoactivable radioactive fluorenone and benzophenone derivatives have been synthesized for the binding site probing. The photoradiolabeled β2AR will be cleaved by proteases and the peptide mapping will be analyzed with polyclonal antibodies to TM5 using Western blotting techniques. By sequencing the protealytic peptides, the binding sites for those ligands can be identified by comparing the obtained sequence with the deduced amino acid sequence of the β2AR from the cDNA.